Core A: Curation and Statistical Analysis Core

CORE A ABSTRACT
Curation and Statistical Analysis Core
Core Director: Kathy Panageas (MSK)
The Curation and Statistical Analysis Core will be co-led by Drs. Katherine Panageas and Deb Schrag, who
have a long-standing role in the AACR GENIE PRISSMM data curation efforts to date. The PRISSMM
framework includes data collection with respect to: Pathology; Radiology; Imaging; Signs and Symptoms; tumor
Markers; and Medical oncologist assessments. The phenomic, therapeutic, and oncologic outcome data are
curated from the electronic health record (EHR) and other institutional data sources according to the patient-
and cancer-centric PRISSMM framework for determination of real-world cancer outcomes. PRISSMM utilizes
a cancer-agnostic curation model that standardizes key components of outcome ascertainment in oncology
based on existing data standards. Specifically, all pathology reports, all radiology reports for imaging studies
other than plain x-rays and ultrasounds, and one medical oncologist note per month are curated. Aim 1 of the
Core will be to develop and maintain data standards to support consistent and transparent abstraction of clinical
data from electronic health records. Curation initiatives require assessment of different components of data
quality throughout the curation process. Multi-pronged QA processes will be implemented and evaluated as
part of the Core to address feasibility, accuracy, and reproducibility. In order to assess whether real world
progression-free survival (PFS) determined using the PRISSMM data model (based on imaging, PFS-I or
based on medical oncologist assessment PFS-M) approximates PFS based on RECIST, the gold standard for
defining disease progression in the clinical trial setting, radiologist measurements will be performed and
interpretations will be compiled with PRISSMM outcomes. The statistical aspects of the design and analysis of
the clinico-genomic analyses in our proposal share many common elements as they relate to analysis of
complex genomic data, nuances of PRISSMM data model and patient populations. Aim 2 of the Core will be to
provide methodologic and biostatistics support and collaboration for individual observational data analysis.
Dedicated shared resources for expert biostatistics and genomics analyses for our P01 program will ensure
the necessary rigor and reproducibility critical to our proposed studies.

Public health relevance
CORE A NARRATIVE The overarching goal of this core is to ascertain “real world” clinical outcomes with rigor and reproducibility and to ensure that the inferences made from the resulting observational databases are reliable and reported with transparency. We accomplish this by coordinating curation and interpretation efforts to apply PRISSMM, a tumor-site agnostic data model to specification of oncologic outcomes from EHR data. Broad availability of high- quality tumor genomic data linked to treatment exposures and survival outcomes will propel further advances in precision oncology and translational research.